Ethics and Policy Core

PROJECT SUMMARY
The goal of the Penn Artificial Intelligence and Technology (PennAITech) Collaboratory is to identify, develop,
evaluate, commercialize, and disseminate innovative technology for monitoring aging adults and persons with
Alzheimer's disease and Alzheimer’s disease related dementias (AD/ADRD) in their home environment and
the artificial intelligence (AI) methods and software for analyzing data generated by those technologies for
improving clinical care. This will help aging Americans live safe, social, and engaged lives. To date, the
science of AI and monitoring technologies has often outpaced existing ethical and policy frameworks, and the
unique ethical and policy implications for older adults, including older adults experiencing cognitive
decline/impairment and their care partners, have largely been overlooked. Therefore, there is a critical need
for ethics and policy scholarship—in conversation both with the science of AI and monitoring technology and
also with the science of aging and AD/ADRD—throughout the research phase, as well as during its translation
into viable interventions. To address this need, the Ethics and Policy Core will work in close collaboration with
the other PennAITech Collaboratory Cores with a focus on four key issues: promoting the autonomy of older
adults by balancing considerations of usefulness and intrusiveness; protecting older adults in light of
vulnerability due to cognitive and functional decline; mitigating bias and addressing health disparities, such as
racial disparities and urban-rural disparities; and safeguarding the data privacy of older adults. In order to
accomplish this, the Ethics and Policy Core has three aims: (1) to provide guidance and training to
PennAITech Collaboratory-funded pilot project leaders, trainees, and industry leaders on ethical and policy
issues encountered in researching and developing AI methods and technologies for healthy aging; (2) to
examine the ethical and policy barriers to using AI methods and technologies for healthy aging from the
perspective of diverse stakeholders, including healthy older adults, adults with AD/ADRD, and care partners;
and (3) to serve as a national resource for the research community by disseminating guidelines and best
practices related to developing AI methods and technologies for healthy aging and translating them into care
with a focus on healthy older adults, adults with AD/ADRD, and care partners. This innovative and impactful
Core will be led by Emily A. Largent, JD, PhD, RN, an authority on bioethical and policy issues in research and
care involving older adults and persons living with AD/ADRD, and it will engage a multidisciplinary team of
experts to reach its overarching goal.

Public health relevance
Successful aging in the home can greatly improve quality of life, improve health outcomes, and reduce burden on the healthcare system. The goal of this project is to establish a national collaboratory for the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate health aging in the home. The Ethics and Policy Core will examine key ethical issues that in designing and disseminating these technologies.